Cell Cycle Control of Arterial-Venous Specification

PROJECT SUMMARY
Establishing a functional vascular network is a rate-limiting step in embryonic development, the repair of injured
tissues, and the engineering of tissue replacements. Although we have made progress in identifying factors that
promote endothelial cell proliferation and sprouting, we lack understanding of mechanisms that coordinately
regulate endothelial cell growth suppression and phenotypic specialization during vascular network formation,
which has created significant roadblocks for clinical therapies, tissue engineering and regenerative medicine.
We aim to circumvent these roadblocks by elucidating fundamental mechanisms of vessel network formation
and repair. Our previous studies, in the postnatal murine retinal vascularization model of sprouting angiogenesis,
revealed that shear stress of different magnitudes promotes differential growth responses and gene expression.
That is, arterial/arteriolar shear stress levels promote Notch signaling, and downstream p27-induced late G1
state, which enables TGF-b1-induced arterial gene expression (Fang 2017; Chavkin 2022). Conversely,
preliminary data show that flow magnitudes typical of veins/venules induce early G1, which we found enables
BMP4-induced upregulation of venous genes (Chavkin 2022). Our preliminary human stem cell studies are
consistent with these findings and show that vessel-specific shear stresses (venous vs. arterial) promote
differential growth responses (early vs. late G1 states), as well as venous vs. arterial gene expression. However,
blood flow is not required for the initiation of arterial-venous specification during embryonic vascular development
(Chong 2011), and whether endothelial cell cycle control is required for this process is unknown. Defining the
role of endothelial cell cycle regulation in embryonic vascular development could reveal a universal mechanism
required to establish arterial-venous networks. Furthermore, identifying novel key regulators of endothelial cell
cycle state and fate can provide new targets for the treatment of diseases associated with endothelial cell
hyperproliferation, including vascular malformations and tumor angiogenesis. Thus, our hypothesis is that
endothelial cell cycle control is required for embryonic arterial and venous specification, its
dysregulation promotes arterial-venous malformations, and manipulation of endothelial cell cycle state
can prevent or regress vascular malformations. We further hypothesize that mechanistic insights gained
from these in vivo studies can be used to optimize the specification of human stem cell-derived arterial
and venous endothelial cells. To ensure scientific rigor, we will test these hypotheses in vivo in models of
arterial-venous network formation and repair, and in vitro in human stem cell-derived endothelial cell culture
systems that allow genetic and flow manipulation to define mechanisms that regulate endothelial cell cycle state
and arterial-venous fate. Evaluation of these hypotheses will yield novel fundamental insights into blood vessel
formation that could improve vascular pathology treatments and human microvasculature engineering to sustain
a variety of tissues.

Public health relevance
PROJECT NARRATIVE We are studying the process of blood vessel formation and trying to understand how the growth of endothelial cells, that form the lining of blood vessels, is regulated and to what extent this is necessary in order to develop a proper blood circulatory system. By defining factors that are needed for endothelial cell growth control and arterial-venous network development, we will gain insights needed to treat arterial-venous malformations, enhance neovascularization of injured tissues, and engineer circulatory networks from human stem cells that can be used for tissue engineering and regenerative medicine applications.